Investigating the role Ikaros variants in multiple myeloma pathophysiology and drug sensitivity

Investigating the role of Ikaros variant in multiple myeloma pathophysiology and drug sensitivity
Multiple myeloma (MM) is a complex and heterogeneous disease in which malignant plasma cells grow and
accumulate within bone marrow, causing end-organ dysfunctions and morbidity. Although survival in MM has
improved significantly, acquisition of resistance in MM patients results in relapse thereby leading to challenges
in disease management. Thus, better understanding of molecular mechanisms underlying the disease is required
for identification of novel resistance/sensitivity prognostic markers. The initial impact in MM treatment came from
the introduction of lenalidomide. Lenalidomide causes selective ubiquitination and degradation of two lymphoid
transcription factors, Ikaros (IKZF1) and Aiolos (IKZF3), by the Cereblon ubiquitin ligase. This established the
dependency of MM cells on IKZF1 for their sustained proliferation and survival. Also, IKZF1 is a critical regulator
of lymphocyte development and differentiation. It is known to act both as activator and repressor of gene
transcription. While examining the differences in 3' end RNA processing between MM patients and normal
plasma cells, it was surprising to find that normal plasma cells express high levels of an IKZF1 variant which is
lost in a group of MM patients. Patients exhibiting this loss also had shorter progression-free survival. As this
variant is generated by combination of alternative splicing and early cleavage and polyadenylation in the intron
of the gene, it is referred as Ikaros intronic cleavage and polyadenylation isoform (IKZF1-IPA). IKZF1-IPA lacks
five 3' exons but contains two alternate 3' exons, and it thus differs in its 3' coding region and 3' untranslated
region (3' UTR), compared to IKZF1-full-length (IKZF1-FL). The encoded IKZF1-IPA has a distinct C-terminus,
which is significantly shorter than IKZF1-FL and lacks all the known DNA binding as well as homo- and hetero-
dimerization domains. Based on these findings and well-established oncogenic role of IKZF1-FL, it is
hypothesized that loss of IKZF1-IPA could contribute to MM pathogenesis by increasing oncogenic IKZF1-FL
levels and loss of tumour suppressive activity of IKZF1-IPA. Another hypothesis is that MM cells exhibit different
sensitives to lenalidomide treatment in presence or absence of IKZF1-IPA. Thus, in AIM1, how loss of IKZF1-
IPA promotes MM pathophysiology will be investigated. As IKZF1-IPA exhibits limited similarity to known IKZF1
isoforms, there is lack of understanding about the binding partners of IKZF1-IPA and its localization preferences.
Identifying its binding partners will provide insight about its molecular modus operandi. It has been demonstrated
that the interaction between IKZF1-FL and other IKZF1 variants impacts its chromatin remodeling activity. Thus,
in AIM 2, the role of IKZF1-IPA in shaping epigenetic landscape, its binding partners and its localization
preferences will be investigated. Understanding the functional role of IKZF1-IPA in MM will advance knowledge
about the resistance and sensitivity pathways in MM. It will also allow to determine if IKZF1-IPA can serve as a
prognostic marker for MM treatment and response. Given the central role of IKZF1 in development, disease, and
treatment, the knowledge gained from this study can be extended to other diseases and malignancies.

Public health relevance
Investigating the role of Ikaros variant in multiple myeloma pathophysiology and drug sensitivity This study will advance our knowledge about the drivers, resistance, and sensitivity pathways of multiple myeloma. It has the potential to identify novel prognostic marker for multiple myeloma treatment and response.